Long Term efficacy of rTMS in Managing MTBI-related Headache

Abstract
Persistent headache is one of the most common debilitating symptoms in military personnel
suffering from mild traumatic brain injury (MTBI). Along with headaches, these patients also suffer
from associated mood and attentional deficit. Conventional analgesics have not been shown to be
effective in managing these debilitating symptoms and consist of untoward side effects and abusive
complication. Our preliminary study indicates a week long course of non-invasive central
neuromodulation method called repetitive transcranial magnetic stimulation (rTMS) at the left motor
cortex (LMC) can significantly alleviate MTB related headache symptoms up to one month without
significant side effects in comparison to sham control. Ongoing prospective clinical survey in patients
receiving treatments also suggests rTMS provides a feasible non-invasive long-term therapeutic option
for MTBI related headache (MTBI-HA) management. This proposal aims to further validate the long-
term effect of rTMS in managing MTBI-HA up to 2-3 months by comparing the treatment effect of
active-rTMS (Group A) to sham-rTMS (Group B) at LMC in: 1) reducing the intensity, frequency and
duration of MTBI-HA and the overall analgesic usage; and 2) improving quality of life, mood and
functions in patients with MTBI.

Public health relevance
Due to recent wars in the Middle East, the number of military personnel suffering from Mild traumatic brain (MTBI) injury increases rapidly. Headache is the most debilitating clinical symptom in veteran and active military personnel with MTBI. Unfortunately, drug treatments for MTBI related headache have not shown to be effective and drugs such as morphine are habit forming and contain long-term abusive side effects. Recently, the use of non-invasive brain stimulation such as repetitive transcranial magnetic stimulation (rTMS) has yielded favorable clinical outcome in a few chronic central pain conditions including pain related to strokes and MTBI related headaches. The treatment, which usually is non-painful and requires no anesthesia, utilizes a coil to non-invasively create a small current in a specific brain region for pain relief. This 4-year study aims to assess the long-term effect of rTMS in reducing MTBI related headache and other co-existing mental problems.